COLD SPRING HARBOR LAB CONF ON MOUSE MOLECULAR GENETICS

DESCRIPTION: (Adapted from the applicant's description) The use of the mouse as a model system for understanding normal development and disease processes has increased dramatically over the last few years. This is due to sophisticated techniques that enable the manipulation of the mouse genome, as well as the increasing number of genetic resources that have become available in the mouse for identifying genes that function in diverse biological processes. The goal of the proposed Cold Spring Harbor Conference on Mouse Molecular Genetics, to be held August 30 to September 3, 2000, 2002, and 2004, is to bring together a diverse group of scientists studying various molecular and genetic aspects of mammalian development and disease. This conference is expected to attract approximately 400 scientists from around the world. This annual meeting will provide a format for the exchange of ideas and information among both new and established scientists for the discussion of the latest research findings and technical advances towards the study of mammalian development and disease, and fosters scientific collaboration. Eight topics (eight sessions) have been selected for detailed discussion as a reflection of the most advanced and interesting areas of study in mouse molecular genetics (genetics, functional genomics, models of human disease, patterning, organogenesis, signals & receptors, neural development, and regeneration biology). Two established scientists per session are invited to present a relatively global perspective of their work (one of which will also act as the chairperson for that session), while the remainder of the talks will be selected from the submitted abstracts. Other participants are able to present their research in one of the two poster sessions to be held during the conference. This format allows the participation of many new scientists, giving them a format to present their latest work.